Structural Variation analysis of Orofacial Cleft associated genomic regions in African and Asian populations

Project Summary
Cleft lip is the 4th most common birth defect in the U.S. and is known to affect annually one in 800 babies worldwide.
The Kids First program aims to uncover the etiology of these diseases and foster data sharing within the
pediatric research community. Expert-Driven Small Projects to Strengthen Gabriella Miller Kids First Discovery
(RFA-RM-22-006) is intended to “engage experts in a variety of activities that will enhance the utility of
childhood cancer and/or structural birth defects genomic datasets generated by the Kids First program and/or
associated phenotypic datasets and resources”. In this proposal we specifically propose to analyze in-depth
the Kids First curated datasets assembled for the cohort Orofacial Cleft: African and Asian Ancestry (253
Families) currently available through the framework CAVATICA at the Kids First data portal.
Currently single nucleotide variation (SNV) analysis in syndromic and non-syndromic OFC has found
functional impairments in genes such as IRF6, BMP4, MAPK3, etc. However, considering that Structural
Variations (SVs) account for more total base-pair variation in human genomes than SNVs, we argue that this
topic is an important and missing component of this Kids First project. Exploring the role of SVs in the
manifestation of the OFC phenotype will require a search beyond gene regions, since intergenic SVs can
cause impairment to normal enhancers and transcription factors. We will explore three main SV types:
deletion, duplication and inversions by looking for common and individual SV alleles that differ from the
parents. We will also look at the OFC associated genes along with the related transcription factors, paralogs
and associated intergenic regions to fully characterize potentially causative SVs. Using a set of preidentified
39 gene loci including IRF6, we will closely survey the 244 triads and use a healthy human cohort to filter the
results (1000 Genome Project Phase 3 study, 2504 samples). This analysis will complement the SNV analysis
for this data that has already been completed and will provide additional context for the total genomic
landscape. We will disseminate our work to the scientific community and compare our results with previous
copy number variation (CNV) literature and share the SV triad workflows we develop to enable a similar
analysis on other Gabriella Miller Kids First Pediatric Research Program (Kids First) datasets.

Public health relevance
Narrative Cleft lip is the 4th most common birth defect in the U.S. and is known to affect annually one in 800 babies worldwide. The Kids First program aims to uncover the etiology of these diseases and foster data sharing within the pediatric research community. We propose to analyze the Structural Variation of the Kids First Orofacial Cleft: African and Asian Ancestry (244 family triads) cohort currently available from the Kids First data portal to improve diagnostic capabilities and therapies for children and their families affected by these conditions. .